Multi-site Feasibility of Compassion Meditation for Veterans with PTSD

PROJECT SUMMARY/ABSTRACT
Posttraumatic stress disorder (PTSD) is a common health concern among Veterans. Although
empirically-supported approaches are widely available, engagement rates are low and partial/non response is
common. There has been considerable interest in the role of complementary and alternative interventions for
PTSD, but little research is available to guide decisions about care. Compassion meditation (CM), a
contemplative practice that is intended to foster connectedness with others, shows promise for the treatment of
PTSD in Veterans. In healthy populations, CM fosters positive emotion and social connectedness, both of
which are known to enhance coping and resilience in the face of extreme stress. Based on this theoretical
rationale, we recently completed a two-phase proof of concept trial of CM for Veterans with PTSD. The first
phase employed qualitative and quantitative procedures to iteratively refine an existing CM protocol, CBCT®
(Cognitively-Based Compassion Training), for Veterans with PTSD. The second phase utilized a pilot
randomized controlled trial to establish the feasibility and acceptability of a randomized trial of CM for Veterans
with PTSD and to examine potential clinical impact. On the basis of promising results, the proposed project will
evaluate the feasibility of a future multi-site efficacy trial of CM for PTSD.
Although our prior work is an encouraging first step, key questions remain. First, our data come from a
single site in Southern California. It is possible that there are regional differences in the acceptability of CM, so
we plan to examine the feasibility of recruiting and retaining Veterans residing in another area as well as
confirming the acceptability of the approach to a more diverse sample. Second, our previous trial relied on a
single therapist, who was actively engaged in the development process. It is important to demonstrate that
others can be trained to deliver the approach with fidelity and to have some confidence that our results are
attributable to the protocol rather than to an individual. Finally, in the interest of ultimately understanding the
way in which these interventions lead to symptom change, we will continue to refine our assessment strategy,
including adding behavioral methodologies to augment what can be gleaned from self-report measures. If
successful, this project will lay the necessary groundwork for an efficacy trial of CM, which ultimately could
provide an additional evidence-based treatment option for Veterans with PTSD.

Public health relevance
PROJECT NARRATIVE Compassion meditation (CM) is a contemplative practice that builds compassion for and connectedness with others. CM has shown promise as a way of enhancing recovery for Veterans with PTSD. The proposed project will examine the feasibility of a clinical trial by assessing our ability to deliver CM and a control intervention consistently at VAs in different parts of the country and optimizing the way in which we will determine outcomes.